Admin Core

ABSTRACT—Administrative Core
The goal of the Program Project is to reduce the burden of hepatocellular carcinoma (HCC)-related mortality
through better understanding of contemporary risk factors (e.g., phenotypic, biochemical and genetic markers of
metabolic dysfunction) and preventive strategies (e.g., chemoprevention) of HCC related to metabolic
(dysfunction) associated fatty liver disease (MAFLD). To accomplish this goal, we propose 3 Projects, 2 shared
resource Cores: Biospecimen and Biomarker Development Core and Data and Analysis Core, and the
Administrative Core. The Administrative Core will govern the Program, run the finances and operations,
coordinate between groups, and support the Program Project.
We propose a well-run Administrative Core with strong and experienced leadership that will be essential to the
success of the Program Project and the studies and cores it supports. Dr. Hashem El-Serag, Chair of the
Department of Medicine at Baylor College of Medicine, Houston will be the Director of the Administrative Core.
Dr. Fasiha Kanwal, Section Chief of Gastroenterology and Hepatology at Baylor College of Medicine will be the
Associate Director. Both are highly experienced running Centers and Cores. One Program Project administrator
will provide the necessary support for day-to-day financial management and operations. An Executive Committee
and an External Advisory Committee will perform oversight. The Executive Committee will be composed of the
Director, Associate Director, Core Directors, and Project Leaders who will meet monthly. The External Advisory
Committee will comprise of 4 external experts in liver cancer biology, epidemiology, prevention as well as
coordinating center activities.
The Aims of the Administrative Core are: (1) to build a Core with strong leadership to manage the Program
Project; (2) to use optimized methods for managing the Program’s scientific, regulatory, and financial functions;
and (3) to support coordination and communication between Program investigators and outside advisors and
collaborators. The Administrative Core will provide centralized administrative and scientific leadership to facilitate
synergistic interactions among all components of the Program Project. The core will provide a platform for
monthly meeting for the PIs of all projects and cores to meet and share progress and results and troubleshoot
problems. The Administrative Core will tracking progress of Projects and Cores against timelines and milestones
via accessible real-time electronic dashboards and evaluating performance of Projects, Cores, and the overall
Program. The Administrative Core will also implement a web-based software to track service use and conduct
webinars, meetings, and conferences. The Executive Committee of the Administrative Core will also provide
platform for investigators to influence the operations of the Program Project.

Public health relevance
PROJECT NARRATIVE The Program Project includes investigators from several institutions conducting three research projects, and supported by two shared resources cores to better understand and reduce the risk of developing the most common type of liver cancer, hepatocellular carcinoma (HCC), among individuals with metabolic dysfunction (e.g., diabetes, obesity). The Administrative Core will provide the overall administration (including financial and operational management), governance, communication, coordination and support for the Program Project. The Administrative Core has a Director, Associate Director, Executive Committee and an External Advisory Committee.